Investigating the role of peripheral nerve damage in chronic Toxoplasma infection

Project Summary
Toxoplasma gondii is a highly successful intracellular parasite estimated to infect up to a third of the world’s
population. T. gondii establishes a chronic infection forming intracellular cysts largely in the central nervous
system (CNS) and skeletal muscle, associated with chronic inflammation and critically, a loss of motor function
in mice. Notably, Toxoplasma’s tropism for the CNS and muscle is in spite of its ability to infect any nucleated
cell type, which is only partially understood, but is related to the induction of differentiation from replicative lytic
tachyzoites, to slow growing, lowly-immunogenic bradyzoite cysts. Prior in vitro work has shown that glycolytic
cells inhibit bradyzoite differentiation, while oxidative cells promote it. While skeletal muscle features both
glycolytic fast twitch muscles and oxidative slow twitch muscles, investigation into parasite distribution within
skeletal muscle is limited. Additionally, while pathology in the CNS and muscle is established, neither pathology
in the peripheral nervous system (PNS), nor the role of any of these tissues in motor function loss has been
directly determined. In preliminary work in T. gondii-infected mice, differential cyst burden between fast and slow
twitch muscle was observed, in addition to immune infiltration into peripheral nerves, accompanied by pathology
to the neuromuscular junction (NMJ) which connects motor neurons and myofibers. In this work, multiple types
of pathology to the NMJ were observed and intriguingly, the findings suggest that the parasite, muscle metabolic
state, and immune response may drive distinct aspects of this pathology. However, how these factors interact is
unclear. The main hypothesis of this proposal is that the parasite, myofiber metabolic state and immune
response all contribute to the loss of motor function. In Aim 1, the impact of myofiber metabolic state on
parasite burden, immune responses, and subsequent NMJ pathology of both muscle types will be investigated.
In Aim 2, to tease apart the roles of the immune system versus parasite in mediating NMJ pathology, the impact
of blocking CD4+ cell-mediated inflammation or blocking T. gondii replication on NMJ morphology and function
will be determined. The overall goal of this research training proposal is to strengthen the candidate’s
understanding of host-parasite interactions and tissue tropisms, and the contributions of the parasite and immune
response(s) to the associated pathology and function of the skeletal muscle and PNS. The results of this proposal
will be broadly applicable to understanding the host-parasite interactions determining tropism, and the impacts
of chronic infection and inflammation on PNS health and function.

Public health relevance
Project Narrative Infection by the parasite Toxoplasma gondii results in loss of motor function in mice, hypothesized to increase predation by the parasite’s definitive host, feline species, and thus allow the parasite to return to the sexual phase of its life cycle. This proposal seeks to understand the role of the peripheral nervous system in this loss of motor function, and the host-parasite interactions determining T. gondii tropism and subsequent pathology. The findings from this work will provide valuable insight into understanding the mechanisms underlying the functional loss which contributes to the passage of this highly successful parasite.